Renovation to expand and enhance NHP housing for HIV/AIDS research at the Emory NPRC

PROJECT SUMMARY (from P51): This application seeks five years of continued support for the
P51 Base Grant (OD 011132) for the Emory National Primate Research Center (EPC) of Emory
University. The overarching goals of EPC are to conduct a research program focused on scientific
problems relevant to human health and the NIH mission by providing resource infrastructure and
expertise in appropriate scientific and veterinary specialties and ensure the Center’s ability to serve
as a resource to Core Scientists, as well as to scientists regionally, nationally and internationally.
During the current reporting period (5/1/2011 to present), EPC has recorded remarkable progress,
as evidenced by numerous (>790) publications, construction of new animal facilities, including a
state-of-the-art transplantation and ABSL3 facility, and progressive expansion of its research funding
base, even in the era of an extremely competitive NIH funding environment. In addition, the Emory
Primate Center has maintained outstanding core research programs and provided resources and
services to a broad multidisciplinary network of affiliate and collaborative investigators throughout
the region and nation. These research programs, which involve the use of a variety of nonhuman
primate species, are directed primarily toward four major research disciplines, representing the
research divisions within EPC: 1) Microbiology and Immunology; 2) Developmental and Cognitive
Neuroscience, 3) Neuropharmacology and Neurologic Diseases and 4) Behavioral Neuroscience
and Psychiatric Disorders. Also, through the Divisions of Animal Resources and Pathology, EPC
provides support for outside investigators conducting research at EPC, consistent with our ORIP-
mandated role as a regional and national resource. Specific aims for the upcoming period of
support include: 1) To carry out basic and translational research using nonhuman primates to
expand knowledge, develop improved treatments, and advance cures that will benefit humanity; 2)
To provide regional and national resources for data, consultative expertise, biologic materials, and
specialized facilities useful in supporting nonhuman primate research; 3) To study basic nonhuman
primate biology and improve nonhuman primate breeding, husbandry and genetic characterization to
better serve the biomedical research community; and 4) To provide research and training
opportunities involving nonhuman primates to graduate and undergraduate students, postdoctoral
fellows, visiting scientists and faculty members. The pursuit of these aims will enhance the Center’s
ability to serve as an enabling resource to Core and Affiliate Scientists for the conduct of nonhuman
primate research, all for the ultimate goal of advancing human health.

Public health relevance
Narrative This administrative supplement application seeks support to renovate space to house SIV infected animals assigned to AIDS studies, enhance our ability to provide social housing and exercise space for animals while assigned to AIDS research and facilitate behavioral testing on AIDS projects at the Emory National Primate Research Center (ENPRC). ENPRC’s mission is to conduct and support innovative biomedical and behavioral research by Core and Affiliated Scientists in order to improve the health and well-being of human and nonhuman primates.